ANTI IGE MONOCLONAL AB BLOCK HUMAN &RHESUS MONKEY LUNG PASSIVE SENSITIZATION

Objectives To develop a passively sensitized model for the study of human and monkey lungs. To use this model to test the ability of substances of blocking sensitization of mast cells and basophils. To use this model to test the safety of inhibitors. IgE antibodies are thought to play an important role in the induction of allergic inflammation of the bronchi. In this study we assessed the capacity of two inhibitors, FcERI-IgG, an immunoadhesin made up of the a -chain of the high affinity IgE receptor joined to a truncated IgG heavy chain, and MaE11, a humanized murine anti-human IgE antibody, to prevent allergen sensitization. Lung parenchyma strips from Rhesus monkeys and humans were passively sensitized for 20 hours with serum from a ragweed-sensitive patient in the presence of 0, 1-, 5-, or 10-fold concentrations of the inhibitors relative to IgE. The parenchymal strips were then suspended in a superfusion apparatus for measurement of isometric tone and collection of superfusate for histamine analysis in response to challenge with antigen E (AgE). Non-sensitized tissues did not react to AgE challenge, whereas AgE challenge of passively sensitized tissues result in a time-dependent parenchymal contraction and histamine release. Both FcERI-IgG and MaE11 completely abolished the AgE-induced contraction and histamine release in a dose dependent manner. In addition, passively sensitized lung tissues failed to respond to direct challenge with either FcERI-IgG or MaE11. The results of this study suggest that FcERI-IgG and MaE11 may have important immunotherapeutic benefit for the amelioration of IgE-mediated diseases. Keywords IgE, human, lung, passive sensitization, in vitro, antibody, asthma model.